Refeyn TwoMP Mass Photometer with MassFluidix Microfluidic High Concentration (HC) Technology

PROJECT SUMMARY
Our understanding of fundamental biological processes is both driven and limited by our
ability to visualize macromolecular structure and organization. Access to rapid
characterization of proteins and nucleic acids at the single-molecule level is now essential
for scientists to push the frontiers of biological research and is critical for the application
of this knowledge for the improvement of human health. This proposal requests funds to
purchase the TwoMP Mass Photometer with MassFluidix Microfluidic Technology
(Refeyn, Inc.) for the analysis of biological molecules in the size range from kilodalton to
megadalton. The fast imaging and high-resolution capabilities of the TwoMP are also
designed to overcome the speed and sample abundance limitations of single-molecule
imaging. We have identified the TwoMP as the sole commercial product which meets our
requirements, is state-of-the-art and cost-effective. This instrument will be a shared
resource in a well-established core facility at Stanford, the Macromolecular Structure
Knowledge Center (MSKC). The TwoMP mass photometer will support more than twenty
cutting edge health care NIH projects described in this proposal. These projects cover a
wide range of topics, including: energy metabolism (Long); drug discovery (Gray);
cholesterol (Welander); gene therapy (Qi); insulin-independent pathways (Svensson);
neurotransmission (Maduke); biomaterials (Mai), brain development (Fame); signaling
(Jackson); peptide biomimicry (Barron); receptors (Barnes); RNA (Das); transcription
factors (Khavari); oxidative damage (Wang); allergy (Jardetzky); mRNA (Martinez);
genome assembly (Straight); autoantibodies (Lanz); nanoparticles (Sharaf); chromatin
architecture (Altemose); celiac disease (Khosla); pandemic viruses (Lin); and vaccine
development (Kim). These studies address critical functional and structural questions
about fundamental biological processes and span NIH research areas with implications
for diverse aspects of human health and disease, including diabetes, cancer, dementia,
obesity, Alzheimer's disease, influenza, and pandemic viruses. The speed and low
sample requirements of the TwoMP instrument are critical for all these projects, where
sample scarcity and instability are often a significant challenge. These combined
capabilities will drastically enhance our NIH funded faculty ability to conduct biophysical
research by providing a shared resource that meets their biomolecular analysis needs.

Public health relevance
PROJECT NARRATIVE This proposal focuses on the use of mass photometry of biomolecular interactions at the single molecule level to understand fundamental biological processes and how disruption of these processes leads to human disease. Stanford University laboratories study a wide range of biomolecules known to cause human disease, from genetic defects to diabetes, obesity, cancer, Alzheimer's, Parkinson's, celiac disease, multiple sclerosis, and viral and bacterial infections. Enhancing Stanford researchers' ability to understand fundamental biomolecular interactions will accelerate the pace of preventing and treating human disease through the development of new vaccines and therapeutics.